Scanner Agnostic Image-Guided Biopsy Platform Employing Advanced Computer Vision and Computer Graphics to Enable Non-Invasive Registration and Dynamic Projection Mapping

PROJECT SUMMARY
Accurate targeting during image-guided biopsy procedures is critical for the diagnosis and
treatment of cancers such as lung, liver, and spine tumors. However, current CT-guided biopsy
workflows rely on static 2D imaging and manual interpretation, which can lead to misdiagnosis,
repeat procedures, and increased patient risk—especially in anatomically complex or mobile
regions affected by respiration. This project proposes the continued development and validation
of Skylight™, an innovative mixed-reality navigation platform that uses non-invasive adhesive
fiducials (SkinDots™) and real-time projection mapping to guide biopsy tools with millimeter-
scale accuracy.
The long-term objective is to reduce diagnostic delays and procedural complications by enabling
dynamic, spatially aware, and intuitive visualization of subsurface anatomy directly on the
patient's body. This Phase II effort will advance Skylight’s capabilities by implementing and
validating a real-time respiratory motion compensation algorithm using tracked external markers
and preoperative imaging. Cadaveric models ventilated with programmable respirators will be
used to simulate realistic anatomical motion and evaluate targeting accuracy across lung, liver,
and spinal lesions.
The specific aims are: (1) to develop and test software algorithms for tracking and
compensating for respiratory motion; (2) to develop a cadaveric model with physiologic
respiratory movement for system evaluation; and (3) to validate Skylight’s accuracy in guiding
biopsies across common anatomical targets. The proposed system has the potential to
significantly improve the safety, efficiency, and diagnostic yield of CT-guided procedures,
aligning with NIH’s mission to improve health through innovative, patient-centered technologies.

Public health relevance
PROJECT NARRATIVE This research aims to improve the accuracy and safety of image-guided cancer biopsies by addressing common limitations such as respiratory motion and targeting error. By enabling real- time, motion-compensated augmented reality guidance using non-invasive tracking, Skylight has the potential to reduce complications, repeat procedures, and diagnostic delays. In the long term, this technology could enhance early cancer detection and intervention, ultimately improving patient outcomes and reducing healthcare costs.